BLR&D Research Career Scientist Award Application

The major area of our research is to understand the causes of, and development treatments for
neurodegenerative diseases and conditions, in particular Multiple Sclerosis (MS). This work includes
repurposing drugs that are FDA-approved for other indications but show benefit in animal models of
MS, making it easier to bring them to the clinic. A better understanding of how these diseases start and
evolve, and identification of interventions will help reduce disease symptoms, as well as social and
economic burdens. Our MS studies have been supported by Merit grants, and recently have developed
into studies of drugs which increase or accelerate remyelination. For this we make use of both animal
models as well as cell culture studies, focusing attention on oligodendrocytes, the cells that produce
myelin; and astrocytes, cells which provide trophic support and energy substrates to neurons and
oligodendrocytes. Recently we discovered that induction of metabolic dysfunction in astrocytes, in this
case by reducing expression of an enzyme that is a risk factor for MS, causes the cells to reduce
production of Coenzyme A, a protein involved in numerous processes including the citric acid cycle,
fatty acid synthesis, and regulation of iron accumulation. These deficiencies can lead to cell damage
and death of astrocytes, as well as of neighboring cells due to reduced astrocyte generation of
protective factors.
Our studies have led us to investigate genetic risk factors that predispose one to developing MS, and
determining the prevalence of these factors in different populations including Veterans of different
ethnic backgrounds. Our original studies showed that a nucleotide variant in a gene called STK11 is
present at higher levels in women with MS; and we confirmed it is also increased in African-Americans
as well as White MS patients; and differs depending upon the type of MS disease. From this work we
began studies of the microbiome of MS patients, looking at bacterial species present in saliva, an easy
to access resource. We first showed that the oral biome differs in MS patients with different disease;
and currently are determining how it differs between MS patients and healthy controls.
A third project in the lab, funded by an NIH U01 grant is to develop methods to reduce the levels of
highly toxic rodenticides in the body. This is an emerging worldwide crisis, as demonstrated by the
outbreaks of poisoning that have occurred in Midwest US; Tampa, FL; and Haifa, Israel. We have
identified one treatment which reduces the biological half lives of rodenticides by up to 5-fold, and are
now optimizing treatments to fully eliminate them from the body. This work also extends to determining
how these rodenticides damage other tissues, including in the CNS, and if myelin levels are reduced.
We have also begun to analyze the gut microbiome of animals exposed to rodenticides, and find
significant differences that could influence rodenticide metabolism and elimination.

Public health relevance
The number of Veterans with multiple sclerosis (MS) is estimated near 30,000; and some studies suggest that MS incidence is higher in certain veterans compared to civilians. Knowledge of the genes that increase risk or severity of MS, will help diagnosis and prognosis of MS. Disease progression is influenced by the microbiome; our studies to identify how the biome differs between MS patients and healthy controls can provide clues to possible causes and new treatments. A major challenge in MS is to restore myelin to normal levels; our drug studies have identified a class of molecules with that property which should be useful for MS as well as other neurological diseases. Our studies to increase clearance of rodenticides from the body will not only reduce toxicity but also minimize downstream neurological consequences, and may be applicable to removing other toxins such as forever chemicals.